Intraoperative Localization of Epileptic Brain Regions Under Sevoflurane Anesthesia.

Drug-resistant, focal epilepsy impacts millions of children, and treatment often requires invasive evaluation. This
process entails identification of intracranial electroencephalography (iEEG) biomarkers such as spike-and-wave
discharges (SWDs), to guide surgical removal of the presumed epileptogenic zone responsible for generating
habitual seizures. In pediatric patients, extra-operative iEEG evidence indicated that a SWD proxy measuring
coupling between delta wave phase and high-frequency oscillation (HFO) amplitude – Modulation Index (MI) –
accurately tracks epileptogenicity. Since MI does not detail the causality of neural propagations, it’s powerful to
also consider iEEG Transfer Entropy (TE), which measures effective connectivity, and dynamic tractography to
provide plausible propagation pathways. Granted, capturing adequate interictal and ictal epileptic events often
requires days of extra-operative iEEG recording, and this procedure is grueling, expensive, and replete with
major risk factors. Thus, development of intra-operative techniques for induction and reliable measurement of
epileptic iEEG biomarkers is imperative to avoid the above pitfalls and help expand utility of one-stage
procedures. Pertinently, sevoflurane anesthesia reversibly activates spike activity, but there is much debate
over its specificity. Preliminary iEEG results in children suggest that sevoflurane may intra-operatively augment
both MI and HFO effective connectivity (TE) in seizure foci. However, large cohort studies are needed to validate
this finding, as it is unknown how sevoflurane impacts intra-operative MI and HFO-TE in healthy versus
epileptogenic brain areas and if these signals spread via major white matter tracts. Thus, the main aims of the
current proposal are to: 1) build normative atlases of intra-operative MI and HFO-TE, at varying
concentrations of sevoflurane, and 2) determine if sevoflurane-induced modulation of these features can
localize seizure foci and predict seizure outcomes. To accomplish these aims, the trainee will map patient
electrodes to 3-dimensional magnetic resonance brain images, quantify the intra-operative iEEG metrics at
stepwise increases of sevoflurane, and combine iEEG effective connectivity with white matter tractography (i.e.
dynamic tractography). Characterizing the endogenous distribution of MI and HFO effective connectivity, with
and without sevoflurane, will provide critical baseline reference for iEEG interpretation. In addition, understanding
how sevoflurane impacts these metrics in epileptic networks is expected to improve interictal localization efforts
during surgery, reduce invasive diagnostic burden by mitigating the need for extra-operative recording, optimize
treatment cost effectiveness, and ultimately improve seizure outcomes. Through this project, the trainee will: (1)
gain insight into and help refine clinical epilepsy treatment, (2) enhance scientific understanding of how neural
oscillatory coupling and effective connectivity respond under sevoflurane, and (3) will undergo a training regimen
to foster development of critical thinking and hypothesis-driven, ethical research design. The cumulative effect
of the research and didactics will provide a critical foundation for the trainee’s career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE This project will use intracranial electroencephalography (iEEG) to characterize the effects of sevoflurane anesthesia on intra-operative phase-amplitude coupling and effective connectivity, and it will determine whether this modulation can identify seizure foci and predict seizure outcomes, during resective surgery for pediatric drug-resistant focal epilepsy. Creating normative atlases of these iEEG-derived metrics will provide critical reference by illuminating the human brain’s endogenous neurophysiology landscape under varying concentrations of sevoflurane. Clinically, establishing inducible tools for intra-operative localization of epileptic brain regions is expected to reduce diagnostic burden, optimize treatment cost effectiveness, avoid the complications associated with extra-operative mapping, facilitate more accurate resection margins, and ultimately lead to better seizure outcomes.